T CELL RECEPTOR REPERTOIRE IN RHEUMATOID ARTHRITIS

Due to our difficulty in obtaining patients, fulfilling the entry criteria of the study and willingness to participate in the study, we have not been able, to date, to enroll any study patients. Screening of eligible patients will continue.